World Anti-Bullying Forum 2023

Project Summary/Abstract
Bullying is an increasingly serious public health concern associated with various negative short
and long term effects for both victims and perpetrators. Despite the pervasiveness of this
problem, programming designed to address bullying shows modest effects. This deficit
highlights an important need for additional international discussion on how to mitigate and end
bullying. The World Anti-Bullying Forum (WABF) is a large, international multidisciplinary
conference focused on engaging various stakeholders from diverse disciplines to promote
discussion and engage in large scale work to further broaden the field's understanding of
bullying. This event is the only one of its kind bringing together scholars, practitioners and youth
advocates from around the globe for a multi-day conference on various forms of youth bullying.
In 2023 the WABF will be held for the first time in the United States, presenting a unique
opportunity for scholars who may not have attended previous events held in Europe. Diversity is
an essential element of the WABF with previous events having representation from all six
continents and over 40 countries. To increase accessibility for students from underrepresented
backgrounds who may otherwise be unable to attend, this funding will be used to provide ten,
$1,000 scholarships to cover the cost of travel and lodging to attend WABF 2023. Scholarship
recipients will also receive free registration to ensure that the event is not cost prohibitive and to
increase the diversity of representation at the event and in the field of bullying research.
Increasing accessibility for these students will not only improve the success of the WABF, but
will also help create a pipeline of diverse scholars who can continue this important work towards
ending youth bullying.

Public health relevance
Project Narrative The World Anti-Bullying Forum (WABF) seeks to engage globally diverse communities, scholars, practitioners and youth, to improve the field's understanding of international youth bullying. By promoting diversity this event will help provide a deeper understanding of the international context of bullying and draw upon approaches used by scholars around the globe to address the complex phenomenon of youth bullying, improving short and long term outcomes for youth.